A global Infectious diseases framework to grow interdisciplinary research

PROJECT SUMMARY / ABSTRACT
In non-pandemic periods, tuberculosis (TB) is the leading killer from a single infectious pathogen, despite
curative antibiotics. Malnutrition, both undernutrition and poor nutrition leading to conditions such as diabetes
mellitus, is the largest risk factor for TB disease globally. Geographical overlap between malnutrition and TB
exposes the interdependent drivers of these co-epidemics of poverty. TB research, like other patient-oriented
science, can often be siloed from interaction with other professional disciplines working in related disease
determinants, methodologies, economics or policy, to name a few. As a mid-career investigator, my work has
evolved from TB and human immunodeficiency virus (HIV) epidemiology, diagnostics development and
evaluation, to interventional clinical trials among vulnerable populations in undernourished settings globally
where our research group increasingly seeks out new expertise beyond epidemiology and pharmacology. This
K24 proposal will allow dedicated time to apply a framework of activities for interdisciplinary researchers in global
health at the University of Virginia (UVA) and our partner institutes. The framework is designed to primarily
support junior faculty engaging in global health research with early or developing funding sources. The
framework is also intended to develop a university wide cadre of global health researchers informing agenda
within UVA’s new global engagement strategy. Doing so will require development of my own skills in mentoring
techniques, new familiarity with scientific methodology and leadership growth which will in turn allow analysis,
design and execution of large-scale team science specific to undernutrition related TB as the emerging direction
in my work. The overall approach is bolstered by rigorous TB and HIV research among undernourished
populations (U01, R01, R21) with accessible specimens and clinical data for new scientific direction,
administrative structure in the Center for Global Health Equity, and ample global junior faculty or near-peer
postdoctoral trainees in funded programs (D43- Tanzania, USDP- South Africa).

Public health relevance
NARRATIVE A framework utilizing theory and best practices derived from experiences in tuberculosis, human immunodeficiency virus and undernutrition research in diverse settings will be developed to grow interdisciplinary global health research. The mid-career clinical scientist will pursue additional experience in mentoring techniques, scientific methodology and leadership that will grow new approaches to team science, while training an estimated five U.S. based junior faculty mentees, and ten/year skills-based mentees resulting in new competitive grant submission by mentees with interdisciplinary and global collaborators.